Translational Research Support Core

The overarching goal of the CURES Translational Research Support Core (TRSC) is to facilitate translation of
research findings on the effects of chemical and non-chemical stressors to the public health arenas of Detroit
and beyond. The TRSC connects CURES members with physical and virtual resources, providing services,
access, and enhanced partnerships. We work with the Administrative Core and its Career Enhancement
Program, the Community Engagement Core (CEC), the Pilot Project Program, the Exposure Signatures
Facility Core and CURES Research Interest Groups to achieve the translational goals advanced by the
CURES Administrative Core. The TRSC offers a suite of tools and resources that enable CURES investigators
and Detroit community partners to draw connections between environmental and social stressors and
pathophysiological outcomes The TRSC has created a multidirectional translational research support pipeline.
An investigator-focused discovery and candidate exploration portal supports development and interpretation of
environmental risk frameworks, and a population-focused platform that optimizes implementation and
engagement to support research to improve early detection, prevention, and/or mitigation strategies for
environmental-related disorders. The TRSC will leverage a palate of state-of-the-art resources to accomplish
three aims: Aim 1: To Coordinate and Facilitate Resource Access. The TRSC will provide training and
consultation on: 1) translational study design; 2) data science and biostatistics; 3) data access, analysis and
visualization for audiences including investigators and community stakeholders. Aim 2: To Facilitate Team
Science. The TRSC will facilitate team science by: 1) developing new and stronger collaborative partnerships;
2) facilitating mechanisms that support effective team performance; 3) providing feedback that quantifies the
impact of team science, and 4) working with the CEC to ensure acknowledgement and integration of the goals
and values of community partners who are central to team science. Aim 3: To Promote Translational
Research. The TRSC will: 1) support publication and presentation of results using accessible language in
multi-media channels; 2) provide training, consultation and educational materials developed under a
translational epidemiology framework; 3) enable translation of results into lay language to disseminate to
community stakeholders as well as local and state government via the CEC. Through these aims, the TRSC
will facilitate productivity of CURES’ translational research capacity on chemical and non-chemical stressors as
they affect human health. We will achieve this by facilitating resource access and promoting EHS team-science
directed toward CEC-identified, community-voiced environmental concerns. These activities will support
Career Enhancement in developing early-stage investigators into the next generation of EHS leaders, and, with
the CEC, promote community advancement of EHS awareness. TRSC will help CURES inform best practices
for enhancing community resilience in Detroit and will serve as an exemplar for other cities across the US.